APOLIPOPROTEIN SYNTHESIS RATES DISORDERS LIPOPROTEIN METABOLISM

We are measuring the rate of VLDL and LDL apolipoprotein B synthesis in subjects with familial combined hyperlipidemia and normal controls.